Mechanisms driving functional connectivity changes in a mouse model of acute septic encephalopathy

Project Summary/Abstract
Acute mental status changes, classified as encephalopathy or delirium, affect a large proportion of hospital
patients and increase morbidity, especially in elderly and/or patients with neurodegenerative diseases. In turn,
increasing evidence shows that these acute insults potentially fuel long term neurodegeneration. Apart from
increased morbidity, these mental status changes also increase length and cost of hospital stays by resulting in
accidents and unnecessary neurological consults, propagating unnecessary delegations of hospital resources.
Despite this major pathologic and monetary burden, little is understood about the underlying mechanisms
leading to acute encephalopathy. This is largely due to the absence of a fully defined animal model and further,
a quick and reliable read out of encephalopathic progression/delirium in an animal model. Many cases of
delirium are triggered by systemic infection, even when the CNS is not directly involved, which leads to a
cascade of inflammatory pathways from or across the blood brain barrier. Studies have shown systemic
infectious insults resulting in an upregulation of common inflammatory mediators within brain tissue that likely
contribute to glial activation and resultant synapse dysregulation. Here, we use lipopolysaccharide (LPS), a cell
wall component on gram negative bacteria known to cause systemic as well as neuroinflammation, as a
systemic agent to model acute septic encephalopathy (ASE) in mice. We follow the impact of this inflammatory
insult in healthy, adult mice. Further, we propose neuroimaging, specifically, recently developed calcium neural
functional connectivity (FC) monitoring, to establish an FC readout of delirium in this model of ASE. Preliminary
data has shown acute degradation of neural functional networks 24Hrs post LPS injection. This project will use
this biomarker as a means to develop a read out of ASE/delirium in an animal model and probe regional
upregulation of inflammatory mediators and synapse integrity during periods of altered FC. I hypothesize that
this acute degradation of FC will parallel behavioral deficits and reflect regional upregulation of inflammatory
mediators resulting in synapse elimination. A battery of behavioral data will be collected and used to help
interpret the model as a whole. Further, development of this animal model will allow for cellular and molecular
studies of this disease to progress, specifically with my additional hypothesis that acute synapse elimination
and microglial priming is complement-mediated. Many studies have pointed to complement, especially protein
C3a, as an important regulator post LPS administration, and complement in general has been show to drive
synaptic pruning during development and elimination in a variety of neuroinflammatory diseases. It will thus be
important to understand the role of complement in acute encephalopathy. This work as a whole sets up a
means to study the underlying mechanisms involved in delirium/ASE and future work will begin investigating
long term impacts on neurodegeneration.

Public health relevance
Project Narrative Up to 30% of general hospital and 80% of intensive care unit patients experience episodes of delirium or acute encephalopathy secondary to systemic infectious insults, which is a large source of morbidity, and potentially, long term neurodegenerative consequences, in the elderly. The absence of a quick, reliable readout of acute encephalopathy or delirium in an animal model has delayed the understanding of the underlying mechanisms responsible for these acute mental status changes. Here, we propose novel neural functional connectivity mapping as a read out of delirium in a mouse model of acute encephalopathy, and investigate potential molecular pathways we hypothesize to be the root cause driving mental status changes.